Dissemination of a tool for data-driven multiscale modeling of brain circuits

Project Summary
Experiments aimed at discovering how the brain works generate vast amounts of data that span multiple scales: from
interactions between individual molecules to waves of electrical activity across the entire brain. Computational
modeling provides a way to integrate and make sense of these data. Through the parent grant U24EB028998 we are
developing and disseminating NetPyNE, a tool for data-driven multiscale modeling of brain circuits. This tool provides
a programmatic and graphical high-level interface to the widely-used NEURON simulator that facilitates the
development, parallel simulation, optimization and analysis of biophysically detailed neuronal circuits. NetPyNE uses
CoreNEURON, an improved simulation engine optimized for parallel simulation on both CPUs and GPUs. Significant
progress has been made towards achieving the parent grant goal of transforming NetPyNE into a solid and well-tested
tool with a fully-featured GUI, and widely disseminating the tool among the scientific community. This is supported by a
growing user base, as evidenced by over 100 models being developed across more than 40 institutions worldwide,
over 30 peer-reviewed publications making use of the tool. NetPyNE has also been integrated or interfaced with
multiple community standards, tools and platforms, including the NeuroML and SONATA, the Open Source Brain,
EBRAINS and The Neuroscience Gateway (NSG), HNN, SciUnit/SciDash, LFPy, and The Virtual Brain.
This supplement proposal aims to explore and evaluate the use of cloud-based GPU resources to accelerate
large-scale biophysically-detailed simulations of brain circuits using NetPyNE and the CoreNERON simulation engine.
CoreNEURON focuses on improving performance by modernizing the legacy NEURON simulation engine to be
optimized for parallel computation on modern architectures, including cloud GPUs. The yield of offloading these
computationally intensive tasks from CPUs to GPUs has been demonstrated on several in-silico models with
speedups of up to 40x. Currently, performance increases have only been implemented and evaluated for a handful of
models. To facilitate the adoption of GPU utilization for large-scale modeling of brain circuits, we will evaluate the
recently published NetPyNE-based somatosensory (S1) and auditory (A1) thalamocortical large-scale models on
cloud GPU resources. We will first evaluate individual simulations on a single GPU node (Aim 1). Next, we will
evaluate, for the first time, the use of clusters of GPU nodes to perform large parameter optimizations by running
many large-scale simulations simultaneously (Aim 2). We will apply rigorous benchmarking measures, including
computation time and memory usage, to evaluate the feasibility of this approach and characterize its benefits across
use cases, including models of different sizes and different cloud configurations. This supplement will enhance the
performance, interoperability and community adoption of NetPyNE, accelerate multiple NIH-funded research projects
that use NetPyNE, and make cloud GPU technologies more accessible to under-resourced institutions and
communities.

Public health relevance
Narrative Despite advances in brain imaging and recording technology understanding the brain remains challenging due to the complex interactions across scales. The NetPyNE software tool facilitates the development of large-scale detailed brain circuit models to integrate brain data and bridge the scales, which involves simulating the electrical and chemical interactions across thousands of neurons and millions of synapses in a brain circuit. We propose exploring the use of state-of-the-art Graphics Processing Units (GPUs) on the cloud to accelerate large-scale brain simulations and improve the computational and cost efficiency of computational neuroscience research, in turn advancing our understanding of brain function and disease.